Metabolic regulation of oxidative phosphorylation in pediatric AML relapse

PROJECT SUMMARY
The overall goal of this research is to determine how lipid metabolism supports oxidative phosphorylation
(OXPHOS) in acute myeloid leukemia (AML) stem cells. Leukemia stem cells (LSC) are responsible for
relapse in AML, and a major goal in the field is identifying novel ways to eradicate AML-LSC. Recently,
lipids have been identified as essential metabolic substrates for AML-LSC; however, the mechanisms
linking lipids and OXPHOS are not known. To address this, I have determined relapse-specific candidate
genes using RNA-Sequencing data from a cohort of pediatric AML patients characterized through the
Therapeutically Applicable Research to Generate Effective Treatments (TARGET) study. The results
suggest that fatty acid oxidation (FAO) is repurposed to drive heme biosynthesis and fuel OXPHOS in AML
relapse. In this K38 StAARTS application, I will test this hypothesis by studying lipid metabolism and
OXPHOS in vitro with AML cell lines and in vivo using pediatric patient-derived xenografts. Aim 1 will use
stable isotope metabolite tracing experiments to determine if palmitate is a key carbon source for heme in
AML cells with LSC properties. Then, Aim 2 will test the effects of a high-fat diet on the growth and
aggressiveness of pediatric AML-LSC xenografts obtained through St. Jude’s Public Resource Of Patient-
derived and Expanded Leukemias (PROPEL) program. AML-LSC from Aim 2 will also be tested for the
effects of a high-fat diet on OXPHOS activity and heme-containing protein content using comprehensive
proteomic profiling through the Duke Molecular Physiology Institute’s Metabolomics and Proteomics Core.
The results from these studies will provide a mechanistic link between lipid metabolism and OXPHOS in
AML-LSC and have the potential to identify new therapeutic targets. My Mentor team, Institutional
Environment and Career Development Plan, together with my clinical Hematology-Oncology fellowship,
will provide a superb training experience that will ensure the success of this research and prepare me for
a future transition to independence as a Pediatric Hematology-Oncology physician scientist.

Public health relevance
PROJECT NARRATIVE Relapse is a leading cause of death in pediatric acute myeloid leukemia (AML), and new therapies are needed for relapsed disease. AML relapse is mediated by leukemia stem cells (LSC), which undergo unique metabolic adaptations in order to survive chemotherapy. Emerging evidence shows that LSC require lipid metabolism to mediate relapse. The purpose of this work is to determine how lipid metabolism supports LSC mitochondria and the process of oxidative phosphorylation. This will be done by studying lipid metabolism in AML cell lines as well as using a high-fat diet to drive AML relapse in mice engrafted with pediatric AML. If successful, this work will improve our understanding of AML biology by providing a mechanistic explanation for the ways in which lipids support LSC during relapse.